Imaging remyelination in multiple sclerosis using metabolic and ultra-short echo time MRI

ABSTRACT
Damage to myelin sheaths and demyelination of axons is a hallmark of multiple sclerosis (MS) leading to
neurological signs and symptoms of MS. Failure to remyelinate is an important factor contributing to disability
accumulation in progressive MS. Presently, there is a lack of non-invasive imaging methods to monitor myelin
changes and remyelination in preclinical and clinical settings.
Formation of new myelin sheaths and remyelination is an energetically demanding process ensured by
oligodendrocytes, which is associated with modulation of cerebral metabolism. Lactate has emerged as an
important metabolite to promote remyelination as it is used by oligodendrocytes for lipid synthesis and myelin
formation. Hyperpolarized 13C magnetic resonance spectroscopic imaging (HP 13C MRSI) is an innovative
metabolic MR method that enables to monitor enzymatic reactions in vivo in real-time. This method opens new
avenues to investigate metabolic alterations and lactate metabolism during successful/unsuccessful
remyelination. Although quantification of myelin levels using noninvasive means remains challenging, a recently
developed acquisition scheme combining ultra-short echo time and magnetization transfer (UTE-MT) has shown
high sensitivity to myelin content in both white and grey matter areas in a demyelinating MS mouse model.
However, UTE-MT imaging has not yet been applied to study early remyelination and therapy response.
In this project, we propose to investigate the potential of HP [1-13C]lactate and UTE-MT imaging to non-invasively
study the role of lactate metabolism and remyelination in two MS mouse models with different remyelination
capabilities, during disease progression and following response to a remyelinating therapy. To do so, HP 13C
MRSI and UTE-MT imaging sessions will be performed at key time points during lesion formation and during
spontaneous recovery/remyelination. Next, HP [1-13C]lactate and UTE-MT will be used to evaluate treatment
response from a remyelinating therapy to investigate HP [1-13C]lactate and UTE-MT potential to serve as
biomarkers of repair. MRI findings will be confirmed using ex vivo correlates of enzyme activities and
histopathological markers for myelin and lesion characterization.
Development and validation of the MR imaging tools proposed here has high potential to increase our knowledge
on mechanisms involved in remyelination success and failure. Importantly, because the methods developed here
are clinically translatable, they hold great promise to providing new tools for diagnosis and monitoring of therapies
in MS, and helping define optimal therapeutic windows to speed up repair and prevent disability accumulation.

Public health relevance
PROJECT NARRATIVE This research will develop and validate new metabolic and anatomical magnetic resonance neuroimaging approaches, which will improve non-invasive monitoring of remyelination processes in multiple sclerosis (MS). Upon clinical translation, the methods developed in this proposal will serve to ameliorate clinical management of MS patients, aid develop and validate new therapies promoting remyelination and recovery and, ultimately, lead to better outcome and patient quality of life.